A new pathway of spinal neurons in neuropathic pain induced by HIV with opioid

Project Summary:
In response to the RFA-MH-18-610---“the FOA invites research grant applications to decipher pathways and
mechanisms responsible for HIV-1 induced central nervous system (CNS) dysfunction”, we focused on
the Areas of Research Interest: “NIDA is interested in understanding the underlying mechanisms whereby
drugs of abuse and HIV infection interact to impair CNS functions mediated through altered neuronal circuits,
neuronal receptors.” The United States currently has an opioid overuse epidemic. Despite the advent of
effective anti-retroviral therapy, HIV-neuropathic pain (HIV-NP) is a common neurological complication as
patients enjoy longer life spans. This serious health issue is further exacerbated by chronic abuse of opiates
often seen in HIV+ individuals, leading, in turn, to increased severity of neurological deficits. HIV and chronic
morphine use/abuse can increase cytokine production resulting in enhanced neuroinflammation. HIV-related
neuron damage is induced either directly by neurotoxic substances or indirectly by activating glial cells
releasing neurotoxic factors (such as, TNFα). Our preliminary data shows that repeated exposure of HIV coat
protein gp120 with morphine decreased neuronal sirtuin (SIRT) 3 expression, an NAD+-dependent
deacetylase that regulates mitochondrial detoxification in the spinal cord dorsal horn (SCDH), and increased
in neuronal mitochondrial superoxide. However, the exact upstream pathways responsible for the loss of
neuronal SIRT3 in the SCDH in the interaction of gp120 and morphine is not clear. Recent studies show that
the epigenetic reader Brd4, one of bromodomain and extraterminal (BET) family of proteins modulates, the
expression of transcriptional factor c-Myc. The epigenetic writer, enhancer of zeste homology 2 (EZH2)
suppresses gene expression via histone methylation (e.g., H3K27me3). Brd4 positively regulates EZH2
transcription through upregulation of c-Myc. In this proposal we will test the hypothesis that neuronal TNFRI-
--Brd4---c-Myc---EZH2 epigenetic pathway mediates the loss of anti-oxidative SIRT3 system in the spinal
cord dorsal horn in HIV/chronic opioid-related neuropathic pain. We will combine molecular and epigenetic
approach, knockout (KO) mice, conditional knockout (cKO) mice, neuron-selective viral vectors,
mitochondrial superoxide imaging, and molecular-pharmacological assays all in vivo to prove novel
mechanisms. Based on the neuronal signal transduction pathway, the results of these studies will provide
insights on the treatment of neuropathic pain of the interaction of HIV and opioids.

Public health relevance
Project Narrative: The opioid epidemic has recently taken a vast toll on American society. HIV-1 and abuse of opioids, such as morphine or heroin, have been described as two linked global health crises. Emerging clinical data suggests that repeated use of opioid pain medications could enhance chronic pain in HIV patients. In this proposal, we will test our hypothesis that neuronal pathway mediates the loss of the anti-oxidative SIRT3 system in the spinal cord dorsal horn in HIV/chronic opioid-related neuropathic pain. This will help researchers and clinicians understand how chronic use of opioids enhances HIV-associated pain, and develop strategies aimed at therapeutic interventions.